CRCNS: Dense longitudinal neuroimaging to evaluate learning in childhood

Understanding how learning occurs in early childhood has the potential to transform our understanding of
human learning and our approach to building intelligent machines, yet critical windows in early childhood
remain under-sampled and consequently provide little insight concerning learning. One fundamental and
long-standing question in human learning is the process by which neural specialization for visual letter
and digit processing emerges in the first grade. This knowledge is critical for addressing public health
concerns related to reading and math literacy because first-grade letter and digit knowledge are the
strongest predictors of future reading and math abilities, and children who fall behind in reading and math
in elementary school will likely experience medical and financial instability as adults. This project employs
a multi-level approach to understanding learning in childhood that will support critical advancements in
several disciplines, including human and artificial learning, developmental and cognitive neuroscience,
educational neuroscience, neuroimaging methods, computer vision, and learning sciences broadly. The
first aim is to create and distribute a large corpus of images from Sesame Street episodes annotated for
educational content, such as letters and digits, as well as for other common object categories. The image
corpus will be the first to capture the visual statistics of child learners and can be used to train different
artificial learning architectures to better understand human learning. The second aim is to collect,
preprocess, and distribute a dense longitudinal MRI dataset of brain structure and function sampled at
multiple time points throughout the first grade year. The dense longitudinal MRI dataset will provide
experimentally measured brain responses to images from the Sesame Street corpus that will be of benefit
for understanding human learning and of appropriate scale for constraining artificial learning architectures.
The third aim is to evaluate the emergence of selective neural processing for letters and digits as learning
occurs throughout the first year of schooling. This aim will address an open question in human learning
concerning the process by which neural specialization for letters and digits emerges, namely the role of
the motor system in emerging specialization. Understanding the time course of changes in brain function
and structure during early learning is critical for developing accurate predictors of long-term life outcomes
and for identifying sensitive windows of great plasticity to optimize intervention timelines.

Public health relevance
This project will investigate brain changes that occur throughout the first year of formal schooling, a year of foundational learning that has consequences for future academic attainment and other major life outcomes. Understanding the brain mechanisms that support emerging reading and mathematics throughout this first year is crucial for developing biomarkers that can identify children at risk of future difficulties and may identify windows of great plasticity within the first-grade year for optimal intervention.